Subtyping tinnitus based on fMRI dynamic functional connectivity

Project summary
Subjective tinnitus is a sensation of ringing or other noise perceived without external sound. People with tinnitus
often experience comorbidities, such as hearing, mental, and sleep problems. Thus, tinnitus can substantially
decrease quality of life and is a major socioeconomic burden. There is currently no objective method for
diagnosing tinnitus or predicting an optimal treatment for an individual. The large interindividual variability of
tinnitus perceptual characteristics and response to tinnitus treatments suggests that many different forms of
tinnitus exist. Interactions between brain regions or “functional connectivity” measured by neuroimaging has
suggested the premise as a biomarker for tinnitus, as it has been shown to correlate with tinnitus characteristics,
change after successful tinnitus treatment, and even predict an outcome of tinnitus treatment. However, relatively
small sample sizes have resulted in inconsistent findings from neuroimaging studies of the heterogeneous
tinnitus population. The limited spatial resolution of the conventional 3T functional magnetic resonance imaging
(fMRI) has also complicated the investigation of the role of subcortical structures in tinnitus. Furthermore, most
studies have ignored the potentially meaningful fluctuations of brain functional connectivity over time.
This K99/R00 project investigates if tinnitus can be subtyped based on the functional connectivity of brain
networks. In the mentored K99 phase, the candidate aims to subtype the UK Biobank fMRI dataset of 7,868
people with tinnitus using state-of-the-art machine learning and individual-level analyses as well as dynamic
functional connectivity that also captures information about functional connectivity fluctuations over time. To
achieve this goal, the candidate will get familiarized with tinnitus research and clinical auditory neuroscience.
Additionally, she will extend her strong background in biomedical engineering with big data, machine learning,
and individual-level analyses. Building on this in the independent R00 phase, the candidate will apply the
methods used in the K99 phase on an ultra-high resolution 7T fMRI dataset that she will measure from 120
participants with tinnitus and 120 controls. The high resolution allows investigation of between-subtype
differences in the small auditory pathway nuclei. Furthermore, to associate the subtyping with more detailed
tinnitus characteristics than available in the UK Biobank, the candidate will also collect a comprehensive set of
questionnaires about tinnitus and its comorbidities and measure psychoacoustic and hearing tests from the same
participants. The study could increase knowledge of the neural basis of tinnitus, and subtyping can lead to more
accurate diagnosis and targeted treatment. The mentored phase is conducted at Athinoula A. Martinos Center
for Biomedical Imaging and Massachusetts Eye & Ear Tinnitus Clinic, which together provide an ideal
environment for the candidate to complement her skillset for launching an independent research program
focusing on the development of neuroimaging biomarkers for tinnitus and other problems related to auditory and
speech processing.

Public health relevance
Subjective tinnitus, defined as perceiving sound in the absence of actual sound affects 10% to 30% of the world population and at least half of tinnitus patients experience comorbidities such as cognitive dysfunction, or depression. This study aims to identify subtypes of tinnitus using state-of-the art neuroimaging, brain connectivity and machine learning methods. Subtyping tinnitus based on dynamic functional connectivity of brain networks would allow more objective, accurate and specific diagnosis, thus being an important step towards personalized tinnitus treatment.